Wisconsin Nathan Shock Center

Abstract Discovery and Integration Core
The Wisconsin Nathan Shock Center (WiNSC) will build upon the remarkable strengths of the University
of Wisconsin-Madison to provide state-of-the-art resources, infrastructure, and expertise in the basic biology of
aging. The central framework of WiNSC is to identify and characterize crucial and novel metabolic aspects of
aging and use this information for translational purposes. The overarching goals of the Discovery and Integration
Core are to establish the necessary infrastructure for integrative data science investigations of complex, multi-
leveled aging studies, build products and capacity that enhances biology of aging research, and provide access
to new and innovative technologies to facilitate mechanistic discovery and translational applied research for
studies focusing on the biology of aging and metabolism.
The Discovery and Integration Core is comprised of three key elements that are designed to investigate
the metabolism of aging and age-related diseases at the cellular and molecular levels, generate new tools and
research avenues, and provide critical insights for translational development. The Integrative Data Science
Partnership is a novel platform and data science matchmaking service that will pair investigators pursuing
complex biology of aging projects with experienced data scientists in a collaborative framework, including the
potential for the data scientist to complete a short residency in the investigator’s lab, enabling deep integration
and aging biology insight. The Innovation Kitchen will solicit ideas from the research community and
competitively select concepts to develop annually that yield tools, techniques, or products that enhance biology
of aging research. The Molecular Profiling Hub includes existing resources at UW-Madison that will be integrated
into Core activities; these will be fee-based and tailored for studies that are aligned with the mission and vision
of the Center. The elements in this Core will enable streamlined integration of basic biology of aging research to
facilitate multidimensional collaborative studies. Importantly, these services will be advertised through links on
the WiNSC website and made available to aging researchers on campus, throughout the Midwest, and the
nation. Projected outcomes include the discovery of the impact of aging on metabolism, the metabolic
contributions to aging and age-associated disease, and the generation of new reagents and research avenues
that will be realized through coordination of efforts with the Energetics of Longevity Core C and the Translation
and Application Core E. The mechanistic data generated here will significantly enrich the potential for translatable
insights afforded through the phenotypic, functional, and translational applied studies described across the
Research Cores. This integrated effort will elevate synergy among projects and investigator-driven WiNSC
sponsored studies, delivering advancement and national impact.

Public health relevance
Project Narrative Not required per RFA-AG-25-012.